Metabotropic Glutamate Receptor 7 as a Novel Therapeutic Target for MECP2 Duplication Syndrome

PROJECT SUMMARY Loss-of-function mutation of the Methyl CpG Binding Protein 2 (MECP2) gene causes a severe neurodevelopmental disorder known as Rett syndrome (RTT), while duplication of its locus leads to MECP2 Duplication syndrome (MDS). Children with each diagnosis can present with profound intellectual disability for which there is currently no treatment. Here we provide preliminary data showing that expression of the metabotropic glutamate receptor 7 (mGlu7), a receptor with known roles in synaptic plasticity and cognition, is altered downstream of changes in MECP2 gene dosage. While potentiation of mGlu7 activity ameliorates phenotypes in RTT mice, the therapeutic potential of mGlu7 modulation in a model of MDS remains unexplored. Completion of this research proposal will thoroughly investigate the efficacy of mGlu7 modulation in paradigms of learning and memory in a mouse model of MDS and provide new mechanistic insight into the neurophysiological role of mGlu7 in the context of MeCP2-related disorders.

Public health relevance
PROJECT NARRATIVE Rett syndrome and MECP2 Duplication syndrome are neurodevelopmental disorders that result from loss of function or overexpression of methyl CpG binding protein 2 (MeCP2), respectively. Currently, patients have very limited treatment options. Studies aimed at understanding the downstream effects of MeCP2 dysregulation are needed to identify novel therapeutic targets for these debilitating disorders.